Impact of phthalate and phenol exposures on congenital heart surgery outcomes.

Abstract
Industrial contaminants in healthcare settings are a largely overlooked source of chemical exposures.
Neonates, particularly those in an intensive care unit, are a highly vulnerable population and may have a
heightened risk for greater chemical exposures as well as adverse outcomes. Bisphenol and phthalate
exposures have been shown to increase following cardiac surgery involving cardiopulmonary bypass (CPB) in
neonates and children and have been detected in common medical devices used in neonatal intensive care
units. Gestational exposures to these chemicals have been shown to negatively impact neurodevelopment,
which remains the most frequent and significant consequence of congenital heart disease and its treatment.
Despite the known presence of these chemicals in healthcare settings and in CPB equipment, no studies have
assessed the influence of exposures during surgery on postoperative outcomes and neurodevelopment. Using
a longitudinal analysis of a randomized controlled trial completed in a neonate population undergoing cardiac
operation with CPB, we propose to characterize trajectories of bisphenol and phthalate exposures in relation to
cardiac surgery by measuring biomarkers in serial urine samples collected pre-operation and 4- and 24-hours
post-operation. We will assess associations of exposures with early clinical outcomes (a previously validated
morbidity-mortality composite outcome, acute kidney injury, hepatic injury, and low cardiac output syndrome)
as well as neurodevelopment at 12-months of age. If our hypotheses are confirmed, reducing bisphenol and
phthalate exposures during neonatal cardiac surgery may be a new avenue for improving postoperative and
neurodevelopmental outcomes in this highly vulnerable neonatal population.

Public health relevance
Project narrative This novel study will provide a deeper understanding of plasticizer exposures and their associations with outcomes following neonatal heart surgery with cardiopulmonary bypass. Our goal is to help guide new interventions to reduce chemical exposures and promote positive outcomes among neonates undergoing heart surgery.